Phase I Clinical Investigation of Episcleral Topotecan in Retinoblastoma

Abstract
Retinoblastoma (RB) is a rare (micro-orphan disease) intraocular cancer in infants and children (typically
diagnosed between birth and 5 years of age). See FDA OOPD orphan drug letter designation for RB in
Appendix documents. Approximately, 250 new cases are diagnosed annually in the United States.
Current standard treatment of affected children consists of either removing the one affected eye (in the
case of unilateral disease), or by giving systemic chemotherapy for a period of 6-9 months, or by giving
multiple regional (intra-arterial) chemotherapy (IAC) infusions. Systemic chemotherapy is associated
with bone-marrow toxicity and relatively high costs. External beam radiotherapy is no longer standard
primary therapy. There has never been an FDA approved intervention for Rb.
Episcleral Topotecan (IND #112785) is a novel system for making possible the sustained local delivery
of Topotecan directly to the interior of the eye without breaching the eye wall (by injection or incision)
while sequestering Topotecan from washout to peripheral circulation. Local Episcleral Topotecan may
reduce or eliminate the need for systemic chemotherapy. Inside the impermeable silicone episcleral
device, the contents of the drug reservoir are maintained in direct contact with a broad expanse of the
outer surface of the eye wall (the episclera), greatly facilitating the net passive unidirectional transscleral
diffusion of the drug to the intraocular tumor inside the eye. Episcleral Topotecan enables sustained-
release delivery of Topotecan with continuous-high-dose Topotecan retinal delivery while eliminating
detectable system exposure and systemic toxicity.
This FDA Orphan Drug Grant application requests funding to support Phase I clinical trials in patients
with advanced unilateral group D retinoblastoma at presentation. In developing countries as many as half
of all children diagnosed with retinoblastoma care are abandoned by the family for cultural or social
reasons (Kumar, A., et al. (2013). "Causes, outcome and prevention of abandonment in retinoblastoma in
India—Pediatr Blood Cancer 60(5): 771-775). Current options for the primary treatment of RB children
include, enucleation, systemic chemotherapy, and IAC. These therapeutic options are invasive, costly
and associated with significant side effects. Episcleral Topotecan offers a potential therapeutic avenue
that is less invasive and less costly with far fewer side effects. It also could be the first FDA-approved
therapy for this micro-orphan childhood disease.
Under Emergency Use protocol, we've treated our first RB patient. This child had failed multiple cycles
of systemic chemo and IAC. The child had >10 refractory tumors and vitreous seeds in his remaining
eye. Post Episcleral Topotecan placement, all tumors and vitreous seeds were resolved by day 28 and all
but two tumors were resolved by day 12. As of day 98 EUA, there was no recurrence. There was no
systemic toxicity and there was no ocular toxicity other than grade 1 vitreous hemorrhage (consider
normal response to tumor response/regression). See letter and retcam images from Brenda Gallie, MD in
Appendix Documents.

Public health relevance
Project Narrative This application requests funds to support the efforts of Targeted Therapy Technologies, LLC (3T) to complete phase I clinical trials in Retinoblastoma (Rb) with Episcleral Topotecan that enables sequestered passive diffusion of Topotecan HCl across the surface of the eye and results in sustained release ocular delivery and avoidance of systemic exposure and toxicity. Specifically, funds requested will support Phase I clinical trials of Episcleral Topotecan in Group D primary disease. The primary objectives/endpoints will be to determine MTD, DLT, and assess tumor response. IND-enabling studies were completed, clinical supplies manufactured, and supportive stability studies conducted under Grant # RC3CA150730—Episcleral Chemotherapy as Salvage Therapy for Eyes with Retinoblastoma (Rb). Episcleral Topotecan has potential to eliminate the need for enucleation, technically complicated interventions such as systemic chemotherapy and Intra-Arterial Chemotherapy (IAC) in eyes with this micro-orphan childhood cancer and significantly reduce the costs and morbidity of treating these infants and children in developed countries. In developing countries, Episcleral Topotecan has potential to be life-saving for most of a life time as abandonment of care is common as required major cancer center resources and technical skills now necessary to treat Rb are frequently unavailable. While Episcleral Topotecan will still require expert care by physicians specialized in Rb, the Episcleral approach will likely dramatically simplify care, reduce morbidity, duration of therapy, and burden on families as Episcleral placement does not require specialized equipment or training and high dose sustained chemotherapy will be available for the first time. As the vast predominance of new Rb cases are diagnosed in developing countries as a result of differential birth rates, Episcleral Topotecan has potential to both reduce morbidity and be life- saving for many children.